Exhaled breath drug detection using differential mobility spectrometry

Project Summary
We have conducted a pilot study using some of the elements in the present proposal that provide support for the
notion that a well selected set of psychomotor/performance tasks can be used to predict driving impairment via
a simulated program. Adding these two approaches to the existing STTR project will add significantly to the value
of the data focused on developing a breath test for THC and its metabolites that could be used on-site or in the
field. The advantage of the present approach is that both measures of performance and quantified THC
concentrations in the individual’s body can be collected in real time with no delays in receiving the results, making
this a much more efficient and accurate measure of impaired driving for law enforcement’s use. Furthermore,
this study will provide data on the effects of various doses of cannabis on a wide range of skills associated with
every day and challenging driving scenarios. Most importantly, this study will provide valuable information on the
residual effects of cannabis that likely play an important role in impaired driving, even though subjective effects
subside within a few hours. Such information will be extremely valuable for making informed decisions on driving
performance by individuals who take medical marijuana and may play a role in developing novel cognitive
behavioral therapies for cannabis use disorders (Hill et al., 2013).

Public health relevance
Project narrative The proposed research will add an assessment of driving ability and a psychomotor performance battery to our existing protocol that measures the concentration of THC and metabolites in breath and blood after acute administration of cannabis.